Mitochondrial pp60Src and cellular metabolism in pulmonary vascular disease associated with CHD

ABSTRACT
Children born with congenital heart defects that cause pulmonary over-circulation develop abnormal pulmonary
vascular reactivity. Although survival has improved, they are at significant risk for developing pulmonary vascular
disease and continue to suffer morbidity and late mortality. Even early pulmonary endothelial dysfunction, with
abnormal vascular reactivity, causes substantial morbidity and mortality. There is an intimate and complex
relationship between cellular metabolism and endothelial dysfunction. However, how these processes are linked
is unresolved, and unraveling novel connections will be the central goal of this Project. Our group is at the
forefront of investigating the role played by post-translational modifications (PTMs) in the metabolic
reprogramming associated with pulmonary vascular disease. In the current funding period, we demonstrated
that modulating pp60Src activity alters phospho-tyrosine (pY) levels within the mitochondria and changes the
assembly and activity of electron transport chain (ETC) Complex I. We identified the Complex I substrates as
NDUFAF5, NDUFS1, NDUFV2, and the specific pY sites. We demonstrated that mitochondrial pp60Src activity
is reduced in pulmonary arterial endothelial cells (ECs) isolated from our lamb model of pulmonary over-
circulation (Shunt). This correlates with decreased Complex I assembly and activity. Exciting pilot data show
that decreases in mitochondrial pp60Src are due to a reduction in the expression of downstream tyrosine
kinase/docking protein-4 (dok-4). Restoring dok-4 levels in Shunt EC rejuvenates mitochondrial bioenergetics
and mitigates the hyperproliferative angiogenic phenotype. c-Jun N-terminal kinase (JNK) activity is increased
in Shunt EC and exhibits increased mitochondrial localization. JNK can phosphorylate SH3 homology-
associated BTK binding protein (SAB) on the outer mitochondrial membrane. Blocking JNK-mediated SAB
phosphorylation increases mitochondrial pp60Src levels in Shunt EC. Based on these extensive data, Project #2
will test the overall hypothesis that pulmonary over-circulation-dependent disruption of endothelial cell
metabolism involves a loss of dok-4 expression, increased JNK-mediated SAB phosphorylation, and attenuated
mitochondrial import of pp60Src. Three Specific Aims (SA) are proposed to test this highly novel hypothesis. SA
#1 will Investigate how the dysregulation of dok-4 disrupts mitochondrial pp60Src import and affects mitochondrial
bioenergetics and NO signaling. SA #2 will investigate how the loss of mitochondrially localized pp60Src
attenuates Complex I activity and stimulates metabolic rewiring to develop a hyperproliferative antiapoptotic
angiogenic EC phenotype. SA#3 will evaluate the therapeutic potential of stimulating mitochondrial pp60Src
activity to prevent the development of the pulmonary vascular disease associated with pulmonary over-
circulation. The successful completion of our proposed studies should yield new mechanistic insights and identify
new targets amenable to therapeutic intervention in children born with congenital heart defects that result in
pulmonary over-circulation.

Public health relevance
PROJECT NARRATIVE The incidence of congenital heart defects in the U.S. is ~1 per 100 live births, and approximately 50% of these children require medical and/or surgical attention. Although survival for these children has improved, they continue to suffer significant morbidity and late mortality, in part because of abnormal vascular reactivity within their lungs. Our studies are designed to increase our understanding of the mitochondrion's role in this process, which could improve the survival of children born with congenital heart defects.